Vibrio colonization determinants in symbiosis

Project Summary/Abstract
The long-term goals of the proposed research program are to provide insight into the complex dialogue that
has evolved between humans and their normal beneficial microbiota. Recent research has indicated a strong
correlation between the successful maintenance of this dialog and life-long health. However, the inaccessibility
of colonized tissues in mammals and the high diversity of their microbiomes render an in-depth study of
persistent colonization of the human gut track extremely challenging. When faced with such complex
phenomena, biologists often turn to simpler model systems to provide insights into evolutionarily conserved
features and reveal basic principles. To decipher the cellular and molecular mechanisms underlying the
chronic association of bacteria with apical surfaces of mucosal epithelia, the proposed program exploits the
specific, binary symbiosis between the bacterium Vibrio fischeri and its squid host, Euprymna scolopes. This
discrete, experimentally tractable, association has been studied for almost three decades as a model for the
long-term colonization of mucosa by Gram-negative bacteria. As in humans, the squid-vibrio association
begins anew each generation, and fosters the continuing health of both partners. The symbiosis can be
initiated with V. fischeri strains with defined mutations, and the host can be bred and maintained for its entire
life. The association can be directly imaged using confocal microscopy, which offers the rare opportunity to
define, with high temporal and spatial resolution, the reciprocal molecular and genetic dialogue in a life-long
beneficial association. This project combines the expertise of the two co-PIs, each with experience in the
biology of one of the symbiotic partners, with additional analytical expertise of three collaborators. Together,
they introduce new approaches and technology to the study of host-microbe interactions, including: reciprocal
epigenomic analyses of the effect of symbiosis on both partners; hybridization-chain-reaction, fluorescent in
situ hybridization (HCR-FISH), which enables visualization of rare transcripts in both host and symbiont cells in
colonized tissues; NanoString Technology, a new method for simultaneous analysis of dozens to hundreds of
targeted transcripts; and, high-efficiency RNAseq, which produces robust transcriptional libraries from as little
as 10 ng total RNA (~100,000 bacteria). Specific aims to be addressed are: (i) determining how a daily
metabolic rhythm is coordinated between a host and its microbiome; (ii) discovering how the symbionts
maintain a rhythmic cycle of growth and persistence; and, (iii) defining the role of epigenetic modifications in
the development and maintenance of a beneficial symbiosis. An understanding of the human microbiome is in
its infancy, and this frontier field is currently at the stage of building paradigms. Within this context, as the
squid-vibrio system has in the past, the results of the current study will shed light upon fundamental principles
that govern persistent colonization by both beneficial and pathogenic microbes.

Public health relevance
Project Narrative The persistent colonization of humans and other animals by their natural microbiome is dependent on a metabolic and physiological communication between the microbiota and host tissues; this reciprocal relationship is often set and maintained by daily rhythms initiated by the host, and can be accompanied by bacterial entry into a non-growing, but physiologically active condition, a strategy also adopted by beneficial microbes in the human gut. Recent work suggests that regulation of these rhythmic activities may involve epigenetic mechanisms, like DNA methylation. A collaborative team of scientists, using a combination of host developmental biology, metabolomic analyses, innovative imaging and transcriptomic techniques, novel applications of epigenomics, and bacterial genetics, will discover the molecular, genomic and metabolic mechanisms that sustain and govern the rhythmic interplay between host cells and their normal beneficial microbiota.